Identifying Clusters of Vision and Eye Health Problems Using Secondary Surveillance Data

To address population vision and eye health problems and disparities, information is needed on the location
and scope of these problems and possible explanatory factors. The NEI Strategic Plan and Notice of Special
Interest ‘Research Addressing Eye and Vision Health Equity/Health Disparities’ both highlight the critical need
for public health disparities research to understand and address these problems. The CDC-funded Vision and
Eye Health Surveillance System (VEHSS) aggregates prevalence information from most eyecare in the United
States, as well as from large national surveys. However, there is yet no systematic mechanism to analyze
these data to identify and locate geographic clusters of vision and eye problems. In this project, we will (Aim 1)
identify and locate geographic clusters with persistently high and/or spiking rates of vision problems and
diagnosed eye disease, or low rates of eyecare service utilization, and (Aim 2) identify and rank community-
level factors associated with clusters of different vision and eye health indicators.
In Aim 1, we will develop an application to access VEHSS public use files (PUFs), conduct scan statistical
analyses, and report identified clusters. For eye disease and eyecare services, we will use county-level
VEHSS public use files aggregated from Medicare Fee for Service, Medicare Advantage, and Medicaid
(including state Children's Health Insurance Programs CHIP); each of which contain prevalence information for
17 eye disorder categories, 79 clinical subcategories, and 28 eyecare services. For vision problems, we will
use ZIP-code level self-reported vision difficulty from the American Community Survey. We will conduct scan
statistical analyses using the NIH-funded SaTScan software to identify clusters in space (overall high
prevalence in groups of counties or ZIP codes) and space-time (spikes in prevalence in these locations). We
will report significant clusters on the VEHSS website to ensure wide dissemination.
In Aim 2, we seek to understand causal or correlated factors associated with identified clusters. First, we will
assemble an analytic file containing community-level characteristics including sociodemographic profiles,
social determinants of health, chronic health risk factors including diabetes, smoking, and hypertension,
correlated conditions including hearing loss and dementia, and environmental risk factors such as pollution.
We will then use machine learning models to predict the geographic clusters and use SHapley Additive
exPlanations (SHAP) analysis to determine which community-level factors had the most positive and negative
predictive power for identifying the presence of clusters of different vision and eye health conditions.
The findings of this project will enhance current vision and eye health surveillance practice by addressing a
critical lack of information on the existence, location, and explanatory factors associated with geographic
clusters of vision and eye problems.

Public health relevance
In the United States, there is no mechanism in place to systematically identify geographic clusters with elevated or increasing prevalence of eye disorders or vision problems or with low or decreasing rates of eyecare services. This project seeks to use scan statistical methods to identify significant clusters of vision problems and eye disease both geographically and over time in Medicare, Medicaid, and American Community Survey data at the county and zip-code level, and then use machine learning methods to identify community level factors associated with these clusters. The findings of this project will identify potentially significant clusters and trends in eye health indicators, as well as identify and rank potentially modifiable community level factors that may contribute to the emergence of clusters which could be used to guide public health practice and interventions.